Use of antiretroviral therapy in older people with HIV during care transition

Project Summary
Background. The number of older people living with HIV (PLWH) in the U.S. is growing rapidly. Half of PLWH
in 2016 were over 50 years of age, with an estimate of 70% by 2030. PLWH have high numbers of
comorbidities, polypharmacy and high hospitalization rates. The transitions between care settings (e.g., home,
hospital, post-acute care, and long-term care) that necessarily occur for PLWH who are aging – and the quality
of care problems that these transitions create – are the focus of this proposal. Previous studies in the general
aging population show that problems with medications are common after a hospitalization; approximately one
fourth did not fill new prescriptions,14% experienced medication discrepancies and almost half were not
adherent to medications following hospitalizations. There is limited data about medication-related quality
problems following hospitalization for PLWH. In a recent study, only 64% of the study patients in the nursing
homes (NHs) used ART. Our preliminary work with Medicare recipients has shown that about two thirds of a
national cohort of NH residents with Part D (Medicare drug coverage) and HIV did not receive an ART during
an average of 1 years of observation in NHs. The purposes of this proposed research are to (1) determine
patterns of ART use in PLWH who made the care transition from outpatient status to NH care; and (2) identify
patient level characteristics and nursing facility characteristics that are associated with the lack of ART use
during NH stays following hospital discharge transitions.
Methods. We propose to conduct a retrospective cohort study including all Medicare fee-for-service NH
residents (2014-2018) nationally. First, we will identify PLWH who had an acute hospitalization that led to a NH
admission. We will follow them to examine ART use during post-hospital discharge NH stays, and follow them
backward in time to the prehospital period to determine whether they were on ART as outpatients. We will
conduct multivariable models to determine correlates of non-ART use following the care transition. Covariates
will include individual level characteristics, such as demographics, polypharmacy, comorbidity status,
hospitalization length of stay and diagnosis; and nursing facility level characteristics such as HIV concentration,
the availability of an AIDS unit and county level HIV prevalence as a proxy of provider HIV experience.
Expected findings and future plans. We expect to observe that a reduction in ART use following the hospital
discharge transition to NHs. ART use is a critical element of high-quality HIV care, and we are concerned that
dropping of an ART regimen at NHs is a marker or indicator of broader quality of care problems. Our study will
identify a clear focus for quality improvement interventions to ensure that PLWH in NHs (absent
contraindications) are using ART. Our methods will also be used to conduct similar studies to ensure that other
medications for chronic conditions are appropriately continued through complex care transitions.

Public health relevance
PROJECT NARRATIVE Our preliminary analysis showed that approximately two thirds of adults with HIV at long-term care facilities did not receive their antiretroviral therapy for HIV care. This proposed project aims to examine the role of care transition from acute hospitalization to nursing home care. We will determine the patterns of ART use and identify modifiable factors that are associated with non-ART use during nursing home stays following hospital discharge transitions.